VITAMIN A AND OCULAR TISSUES

Enzyme-linked immunosorbent assay (ELISA) was used to quantitate interphoto-receptor retinoid-binding protein (IRBP) in retinoblastoma tumors and in human subretinal fluid (SRF) samples. In retinoblastoma tumors there was a direct correlation between the degree of differentiation of the tumors and IRBP concentration. Higher concentrations of IRBP were found only in the more recent rhegmatogenous detachments, and IRBP was absent from SRF of patients with retrolental fibroplasia. Cyanogen bromide peptides from purified bovine IRBP were purified by high performance liquid chromatography (HPLC) and several peptides were found to produce experimental autoimmune uveitis (EAU) in rats. IRBP was shown to be phosphorylated in a crude bovine interphotoreceptor matrix (IPM) wash, and the phosphorylation was of serine and/or threonine residues. Intravitreal injection of radiolabeled retinol or fatty acids into frog eyes showed both retinol and fatty acids to be bound to IRBP.